Glycosaminoglycans to Treat and Prevent Radiation-Induced Oral Mucositis

Project Summary/Abstract
Oral mucositis is a devastatingly painful inflammatory disease that frequently develops during cancer therapy
and affects half a million Americans. The accompanying pain is so severe that patients often require narcotic
pain medicines. The clinical manifestations are ulcers in the mouth and gastrointestinal tract, which are
exacerbated by opportunistic infections. Many patients also suffer from dry mouth causing difficulty in
swallowing because of the decreased salivary gland function. As a result, these patients often need feeding
tubes which interrupts their cancer treatment. The financial burden to the patient is staggeringly high, costing
an additional $17,000 to $40,000 for each patient. Preventing oral mucositis will greatly enhance the cancer
therapy as well as the wellness of the patients. GlycoMira's lead candidate, GM-1111, is a new class of anti-
inflammatory drugs that modulate an overactive innate immune system when administered via once daily
subcutaneous injection. The SBIR Phase I and II study results demonstrate its powerful efficacy in reducing the
severity and the occurrence of the disease in radiation-induced oral mucositis models: GM-1111 reduced
tissue ulceration and inflammation in the tongue. Histologically, oral tissues from the GM-1111 treated group
showed markedly reduced damages in the epithelium with mild infiltration of leukocytes, thicker mucosal layers
and prevention of mucous glandular alterations compared to the tissues from vehicle treated controls.
Biochemical and gene expression analyses of the diseased tissues revealed increased expression of Toll-like
receptors, NLRP3 inflammasome as well as their downstream pro-inflammatory cytokines all of which were
reduced with GM-1111 treatment. Overall, the data suggest that GM-1111 has substantial potential to reduce
oral mucositis in humans. GlycoMira also manufactured cGMP compliant GM-1111 and generated its
manufacturing specifications. To further develop a commercially viable therapeutic for oral mucositis, we
propose studies that will be used for the Investigative New Drug (IND) application to the FDA for clinical trials.
The objectives are to (1) delineate the safety profiles of GM-1111 in nonclinical studies and (2) manufacture
clinical trial ready sterile drug product (aseptic fill/finish and labeling/packaging) and test its stability. The
results of the proposed research will lead the drug development to the clinical stage through IND application
and propel the commercialization of the drug to the patients suffering from this devastating disease.

Public health relevance
Project Narrative GlycoMira seeks to develop a simple, pathology-based treatment for oral mucositis, a common and debilitating complication of cancer treatment. Cancer patients undergoing radiation therapy develop painful, severe ulcerations of the mouth that seriously degrade the patient’s quality of life and compromise treatment and prognosis because their presence causes the physician to interrupt the course of cancer therapy.